Prospective renal insufficiency cohort evaluation: PRICE

PROJECT SUMMARY
This application is submitted in response to RFA-DK-22-502, “Limited Competition: Continuation
of the Chronic Renal Insufficiency Cohort (CRIC) Study (U01)” on behalf of the University of
Pennsylvania (Penn) Clinical Center. Chronic kidney disease (CKD) affects over 37 million
Americans who are at risk of progression to end stage kidney disease and development of
cardiovascular disease (CV) and other comorbidities associated with disability, high costs of
care and premature mortality. Since its inception in 2001, the CRIC Study has recruited and
followed a racially and ethnically diverse cohort of 5,625 participants with reduced kidney
function from 13 recruitment sites at 7 Clinical Centers across the US. The Penn site has
contributed significantly to CRIC and recruited 723 or 12.8 % of the participants. The original
aim of CRIC was to establish a clinical research laboratory designed to (a) identify novel
predictors of CKD progression, and (b) characterize the manifestations of CV disease and
identify its risk factors among individuals with CKD. As the landmark prospective cohort study of
CKD, the CRIC Study has accomplished extensive biological, physiological, and social
phenotyping, longitudinal follow-up, and ascertainment of clinical and patient-centered
outcomes across multiple domains. Findings from the CRIC Study have defined trajectories of
CKD progression, catalogued development and evolution of comorbidities in CKD, and identified
a diverse array of factors and pathways that explain the progression and complications of CKD
in adults. Through its highly productive Ancillary Studies and Opportunity Pool Programs, both
the scientific scope of the CRIC Study and the community of kidney disease researchers have
been markedly expanded. During the most recent funding cycle (Phase 4: 2018-2023), three
innovative sub-protocol studies were implemented to enrich CRIC data with home-based
assessments of kidney function and CV measures. During the fifth and final phase of the CRIC
Study, the major focus will be to (1) ascertain the clinical outcomes for all participants including
those enrolled in the Phase 4 sub-protocols, (2) perform analyses linking the sub-protocol
measurements to clinical outcomes, (3) integrate data from multiple domains to identify sub-
phenotypes underlying the heterogeneity in CKD progression outcomes, (4) conduct final study
visits for the full CRIC cohort eligible for Phase 5, (5) create mechanisms for future data
collection via linkages with external sources of health data, and (6) generate tools and
resources to facilitate ongoing use of CRIC data and biospecimens by a broad group of
investigators after the CRIC Study has officially ended.

Public health relevance
The CRIC study was to established in 2003 to study chronic kidney disease (CKD) progression by identifying novel predictors of CKD progression and risk factors for cardiovascular disease among individuals with CKD. The CRIC Study recruited and followed a racially and ethnically diverse cohort of 5,625 participants and has defined trajectories of CKD progression, catalogued development, and evolution of comorbidities in CKD, and identified a diverse array of factors that explain the progression and complications of CKD in adults. The final phase of CRIC will focus on ascertaining clinical outcomes for all participants including those enrolled in the at home sub-protocols and integrate data from multiple domains to identify sub-phenotypes underlying the heterogeneity in CKD progression outcomes and create mechanisms for future data collection via linkages with external sources of health data to generate tools and resources to facilitate ongoing use of CRIC data and biospecimens by a broad group of investigators in the future.